Decoding dynamic interplay between signaling and membranes in chemotaxis bymolecular actuators

Parent R35 grant
“Decoding dynamic interplay between signaling and membranes in chemotaxis by molecular
actuators”
Proposal Summary
Chemotaxis occurs during a number of key physiological events including angiogenesis,
embryonic development and wound healing. It also contributes to disease progression in
pathological conditions such as cancer metastasis and arthritis. The goal of the current proposal
is to reveal how biochemical reactions and physical characteristics, such as membrane curvature,
deformation, and assembly phase, interact with one another in achieving dynamic, accurate yet
highly efficient cell migration. Chemotaxis has been understood mainly in the perspective of signal
transduction, while if and how physical properties of membranes play a role, and how they interact
with signal transduction remain largely unknown. By newly developing and implementing a series
of molecular actuators that can directly probe membrane properties with high spatio-temporal
precision inside lively migrating cells, we will reveal an interplay between signal transduction and
membrane mechanics.
What molecular mechanisms generate local membrane curvatures developing into
filopodia and lamellipodia? In sensing chemoattractants, cells polarize by undergoing
asymmetric membrane deformation consisting of filopodia and lamellipodia at the front, and
membrane retraction at the rear. We recently found that curvature-sensitive proteins are a missing
link between actin cytoskeleton and membranes. The result made us hypothesize that actin
machinery and curvature sensing and remodeling proteins, when properly modulated in a
feedback loop, are sufficient to produce desired types of membrane deformations such as
lamellipodia and filopodia. We will thus identify a particular combination of Rho GTPases, actin
regulators, and BAR proteins, and the molecular logic thereof, that are responsible for formation
of filopodia and lamellipodia.
How do signaling components in migrating cells respond to membrane deformation?
Migrating cells exhibit dynamic morphological changes at plasma membranes and nuclear
envelopes “as a consequence” of cytoskeletal rearrangement regulated by signal components.
To explore a possibility that membrane deformation talks back to cytoskeletal and signal
components, we will deploy molecular actuators that can directly deform membranes. We will
then quantify subsequently emerging activity of signaling components such as receptor tyrosine
kinases, PI3K, and small GTPases, as well as transcription factors such as YAP and Elk.
How does the phase-separated cytoskeletal biomolecular condensate play a role in
membrane deformation? Actin networks can undergo formation of biomolecular condensates at
the plasma membrane due to weak multivalent interactions among actin regulators. To examine
the physiological importance of such phase separation events, we will adapt molecular techniques
to assemble or disassemble the condensates. These operations will uniquely achieve gain- or
loss-of function manipulations without altering an amount of the molecular constituents; what is
altered is their physical assembly status. We will characterize cell migration phenotypes before
and after deploying phase manipulations.

Public health relevance
Parent R35 grant “Decoding dynamic interplay between signaling and membranes in chemotaxis by molecular actuators” Project Narrative Due to its significant involvement in biological processes, chemotaxis contributes to disease progression in cancer and arthritis, while its impairment leads to anomalous tissue development or regeneration. Our unique molecular actuators that can exert “physical force” specifically onto intended intracellular objects, can be a tool for not only dissecting the molecular mechanisms of chemotaxis, but also interfering with these cell migration-related diseases.